Administrative Core

Administrative Core (Core A) Summary
The goal of the Administrative Core is to provide leadership and overall administrative management to the
Program to ensure implementation of the vision of the Program Project as an integrated investigation of
mechanisms of estradiol effects on the brain and cognitive trajectory under conditions of cardiometabolic
health and disease. The Administrative Core has the following Specific Aims. 1) To provide financial
management and general administrative support to all projects and cores. The Administrative Core will assume
fiscal responsibility for the Program, ensure that all regulatory and reporting requirements are met, and
manage the day-to-day Program activities. 2) To provide expert biostatistical and experimental design support.
The Administrative Core will oversee all statistical approaches used within the PPG. This will include methods
used within projects as well as for comparison across studies. The Core will advise on study design and results
reporting. 3) To provide oversight of data management. The Administrative Core will implement a Program
Data Monitoring Plan that will specify procedures for quality assurance and quality control of data. The Core
will oversee data security and facilitate data sharing among the projects and cores. The Core will also ensure
the collection of valid and reliable data. 4) To facilitate communication and coordination between projects and
cores. The Administrative Core will organize monthly meetings of the Executive Committee that includes
Research Project and Core Leads, monthly Program-wide scientific meetings, and an annual Program-hosted
seminar. 5) To organize and support meetings of the Advisory Boards. The Administrative Core will be
responsible for the logistics associated with organizing biannual and annual meetings of the respective Internal
and External Advisory Committees. 6) To provide and coordinate plans for joint dissemination of study results.
The Administrative Core will implement procedures for joint dissemination of results in two primary areas: joint
submissions of symposia proposals and manuscripts. 7) To conduct an annual evaluation of the Program
Project. The Administrative Core will oversee an annual review of all projects and cores. The review will also
include metrics to measure the success of the PPG as a synergistic research program. The Core will generate
and distribute a report summarizing the review to the Executive Committee and Advisory Boards. Any resulting
recommendations for improvement will be implemented with oversight from the Administrative Core.